Bridging Disparate Structural/Functional Scales: Multiscale Modeling of Genome Organization and of Viral RNA Frameshifting

Abstract
As advances in both experimental and computational biology lead to exciting discoveries in many ﬁelds
of biology and biomedicine today, new avenues to diagnose and treat human disease are becoming a reality.
Molecular dynamics and other simulation approaches play a key role in these connections by helping deﬁne
the underlying biophysical mechanisms, at unprecedented resolution. The PI's computational biophysics lab
focuses on solving fundamental structural and functional challenges concerning nucleic acids and their complexes
(notably chromatin and RNA), in collaboration with experimentalists, by innovative molecular models and
simulation methods using ideas from mathematics, computer science, engineering, biology, and chemistry. This
MIRA project would continue to advance our fundamental understanding of genome organization and RNA motifs
using multiscale models that bridge disparate spatial and temporal scales to generate biophysical insights into
genome folding and cancer genomics, and RNA conformational landscapes/ viral mechanisms. For chromatin and
chromosomes, modeled nucleosomes and their protein complexes at atomic resolution, and chromatin ﬁbers at the
mesoscale, will be linked to data from genome-wide and cancer epigenomics studies to determine the modulation
of chromatin higher-order structure in processes of aberrant gene expression. Speciﬁcally, we will focus on the
structural role and mechanisms of proteins (like CTCF and H1) in gene looping and formation of topologically
associated domains (TADs) and nuclear compartments in gene activation or repression in cancer cells. For RNA,
our topological approach to modeling RNA secondary structure by coarse-grained graphs (RAG: RNA-As-Graphs),
combined with atomic biophysical modeling, will delineate programmed ribosomal frameshifting mechanisms in
RNA coronaviruses and other viruses, and advance the RNA motif atlas. Speciﬁcally, conformational dynamics
associated with the RNA frameshifting element of SARS-CoV-2, along with evolutionary and biophysical analysis
and chemical reactivity experiments, will describe frameshifting transitions and identify/test experimentally
structure-altering mutations that may hamper frameshifting. RAG will also be applied to deﬁne a virus topology
atlas and explore virus motifs from an RNA repertoire point of view, to help understand the RNA motif universe
and advance novel RNA design. The unraveled biophysical mechanisms in genome organization and RNA
frameshifting/conformational repertoire have translational ramiﬁcations for human cancers and viral infections
by coronaviruses or HIV. For cancer therapy, a targeted re-expression of silenced genes may be possible by
chromatin topological changes (e.g., loop dissolution) and RNA editing. For viral RNA infections, new strategies
for gene and anti-viral therapy emerge from this research, feasible by modern RNA editing technologies. The
resulting multidisciplinary computational paradigms are widely applicable to other biomolecular processes and
will be shared with the community at large.

Public health relevance
Relevance Using new multiscale biomolecular modeling and simulation methods that can yield mechanistic insights, Schlick's multidisciplinary team will address fundamental challenges in biology in relation to human disease: genome reorganization in cancer processes and RNA co-transcriptional folding in viral mechanisms. A linking of the many relevant biological scales and heterogeneous features of each is essential for understanding the complex biological activities of these macromolecules in the cellular environment and how they aﬀect gene expression, cancer progression, and viral infection. Such an improved understanding of the organization and transition mechanisms associated with the genetic material and its RNA cousin, together with establishment of systematic methods for their study, has direct medical ramiﬁcations by suggesting speciﬁc molecular design and targeted therapies for the treatment of genetic syndromes, degenerative diseases, cancers associated with chromosomal or epigenetic abnormalities, and viral infections like Covid-19.